Center for Modeling Complex Interactions

Biomedical problems are innately complex, and their solutions require input from many fields. Many centers
focus on a single disease or organ system. By contrast, the Center for Modeling Complex Interactions focuses
on an approach that can address many biomedical problems: team-based, interdisciplinary research centered
around modeling. Our goal is to support and facilitate biomedical discovery by integrating modeling into
interdisciplinary research. Modeling improves research at all stages, from hypothesis formulation and
experimental design to analysis and interpretation, providing a unifying language that highlights commonalities
and uncovers connections between problems. Formalization of ideas into this unifying language also improves
rigor and reproducibility. We define modeling broadly to include everything from deterministic and stochastic
mathematical approaches to physical and computational models of three-dimensional objects, to agent-based
and machine learning approaches. We seek to support modelers by increasing their numbers, and by giving
them opportunities to play productive roles in interdisciplinary teams. We also seek to support empiricists by
giving them access to relevant modeling expertise, and by creating a community and a culture to facilitate
interdisciplinary research. In Phase 1, the Center for Modeling Complex Interactions created the intellectual,
cultural, and physical environment to promote team-based, interdisciplinary research. In Phase 2, we built on
that foundation and created an even stronger interdisciplinary culture to foster collaboration among people who
might otherwise never connect, and by adding additional faculty to expand our modeling expertise. In Phase 3
we have four Aims: (1) Support faculty to carry out model-based, interdisciplinary biomedical research and
increase their competitiveness for external funding. Research in the Center is carried out in the context of
Working Groups—zero-barrier, interdisciplinary, goal-focused teams that meet regularly to get work done.
Supported research includes Pilot Projects, Modeling Access Grants, Data Access Grants and ad hoc teams.
Our comprehensive plan for proposal preparation improves grantsmanship, and our staff assists with
submission and grant management. (2) Increase University of Idaho’s faculty participation in biomedical
research. We will invest time and resources in the existing faculty by providing mentoring, proposal
development assistance, and social writing events. (3) Extend the reach of the Modeling Core into new areas
of modeling to capitalize on emerging opportunities. The Modeling Core will develop Core Initiatives, focused
on areas of modeling of broad interest to the campus community with high potential for growth. The first such
initiative will be on digital twins. (4) Establish a path to long-term sustainability under the umbrella of the
Institute for Modeling Collaboration & Innovation. A key strategy for sustainability is to maintain our status as a
university institute; this provides funds for staff and Modeling Core postdocs. We will maintain engagement by
Center participants to catalyze interactions and promote future interdisciplinary biomedical projects.

Public health relevance
Human health is determined by interactions of complex biological systems at multiple scales, from the ecological to the biophysical; these are layered with spatial and temporal variation. Deciphering these systems requires predictive modeling, coupled with strong empirical work, to be guided by and to feed the models. The Center for Modeling Complex Interactions generates model-based biomedical research and connects people who might otherwise never interact, enhancing the strong interdisciplinary culture of the University of Idaho.